Assay Core

Summary Core A measures serum, serum ultrafiltrate, plasma and urine stone risk chemistries and calculates urine supersaturations for patients studied in Projects 1 and 2. These measurements are used for fulfillment of aims within all four central program project objectives. Upper limit of metastability (ULM) for calcium oxalate and calcium phosphate in urine will be measured for Project 1. Core A will also measure plasma renin for Project 1. Blood and urine samples are processed and shipped for assay of lithium done in Core B, measurement of inflammatory markers in Core D and measurement of intact parathyroid hormone (PTH), aldosterone, 25(OH)- vitamin D and 1,25-dihydroxyvitamin D (performed by LabCorp). Urine exosomes will be prepared for molecular expression studies of renal ion transporter proteins. Aliquots of all blood and urine specimens are stored at -80°C for future use. All laboratory data from Core A for all projects are consolidated into a single database with daily backup for security and ease of analysis. Ultimately, data from the other projects and cores (e.g. histology, biopsy, stone analysis etc.) will be consolidated into our database so that it can be analyzed along with serum and urine data.

Public health relevance
Narrative Core A performs blood and urine assays and renal ion transporter studies to characterize the abnormalities of renal calcium reabsorption that lead to renal papillary calcifications and calcium stone formation. Data from Core A will help in establishing links between metabolic abnormalities (Project 1), histopathology (Project 3), and renal papillary disease phenotype (Project 2), as well as understanding mechanisms of action of therapies commonly used to treat stone disease.